Immunological consequences of LINE-1 expression in cancer

Project Summary
Approximately 200,000 new cases of ovarian cancer (OC) occur per year, but overall survival has not
significantly changed for decades and novel therapies are urgently needed. High grade serous OC makes up
about 70% of cases. It is most commonly derived from the fallopian tube epithelium and is characterized by
nearly 100% mutant TP53 and high expression of transposable elements (TEs). Nearly half of our genome is
composed of TEs, and their transcription is tightly regulated during development. Select TEs are expressed at
high levels in embryonic stem cells, but most are silenced by DNA methylation and repressive histone
modifications in differentiated cells. As part of the global epigenetic dysregulation that cells undergo during
transformation from normal to cancer, TE silencing is compromised and TEs become transcribed. Recent
studies from our group and others have implicated TEs in control of innate immune signaling in OC. Our
studies in a cancer progression model show that LINE-1 elements lose methylation and are transcribed
specifically during cellular transformation rather than immortalization. LINE-1 is the only protein-coding TE
known to be able to retrotranspose, and LINE-1 is significantly overexpressed in OC. We showed that LINE-1
is expressed after P53 mutation in OC precursor lesions and that wild type and mutant P53 transcriptionally
regulate LINE-1 in OC cell lines. Finally, LINE-1 activation in the absence of P53 interferes with DNA
replication to activate the DNA damage response in cancer cells. We know that LINE-1 and other TEs become
activated during cancer progression but we do not understand how this occurs or the immune effects of this
activation. The objective of this application is thus to uncover the biological mechanisms by which epigenetic
dysregulation of LINE-1 changes the OC tumor microenvironment. We hypothesize that by loss of epigenetic
regulation, LINE-1 contributes to OC immune evasion. We will test this hypothesis with the following Aims: 1)
Determine effects of LINE-1 expression on innate immune signaling, 2) Determine effects of LINE-1
retrotransposition on innate immune signaling, and 3) Determine how LINE-1 expression affects the OC
immune microenvironment. Using existing immortalized fallopian tube lines with wild type, mutant, and null
P53, we will transform the lines with the C-Myc oncogene. We will perform genome-wide characterization of
LINE elements during transformation and will assess effects of LINE-1 expression on the DNA damage
response and the tumor immune microenvironment. Taken together, the experiments described in this
proposal will add to our knowledge of epigenetic regulation and immune activity of an understudied 20% of our
genome, LINE-1 elements. These experiments will enable us to identify potential OC driving alterations and
vulnerabilities to novel immunotherapies.

Public health relevance
Project Narrative Approximately 200,000 new cases of ovarian cancer occur per year worldwide, but the overall survival of ovarian cancer has not significantly changed for decades. Nearly 20% of our genome is composed of LINE-1 transposable elements that are tightly silenced in normal tissues but gain expression in cancers, especially ovarian cancer. This project will determine how LINE-1 contributes to ovarian cancer immune evasion, potentially identifying vulnerabilities to novel therapies.